Policy determinants of substance use and treatment access for individuals registered as sex offenders in Philadelphia: a Qualitative investigation

PROJECT SUMMARY
The purpose of this resubmitted Dissertation Research Award (R36) is to support the completion
of a dissertation research project that will lay the foundation for a successful career as an
independent investigator who conducts place-based, policy-relevant research examining and
addressing the structural determinants of substance use among vulnerable, criminal-legally
involved populations. People convicted of sexual offenses and required to register as sex
offenders (PRR) under sex offender registration and notification (SORN) policies are a particularly
stigmatized subpopulation of people involved in the criminal legal system, and are an important
but understudied subgroup who may be disproportionately impacted by substance use and
treatment need. Evidence consistently demonstrates that SORN policies do not deter sexual
offending or serve a public safety function but do have wide-ranging and significantly destabilizing
collateral consequences for PRR, who face material and social restrictions as direct and indirect
results of SORN policies. These include: housing instability, unemployment, isolation/alienation,
poor mental health, abandonment by social networks, exclusions from community spaces, and
overt discrimination, harassment and vigilantism. Simultaneously, SORN policies limit PRR
access to and eligibility for substance use treatment and harm reduction services. While no
existing literature has examined harms associated with substance use in the context of collateral
consequences for PRRs, it is likely that, given the known relationships among economic, social,
and structural vulnerabilities and substance use, SORN policies increase PRRs’ risk of substance
related harms, and contribute to elevated levels of substance use disorder among PRRs. The
goal of this proposed research is to address this important gap in knowledge and provide evidence
for future interventions that will improve both public health and public safety. This goal will be
achieved by qualitatively exploring the relationship between SORN policies and patterns of
substance use and treatment access through 1) 30 semi-structured stakeholder interviews with
attorneys, probation officers, substance use and sex offender treatment providers, and reentry
case managers to elucidate the substance use and policy landscape for PRR and 2) 50 semi-
structured interviews with PRR to reveal how the policy environment impacts access to substance
use treatment and other social services, and influences the lived experiences of people subject
to SORN. This dissertation project will support growth towards research independence, and will
lay the groundwork for a future program of policy-relevant research examining and addressing
how SORN policies operate as structural determinants of behavioral and social health.

Public health relevance
PROJECT NARRATIVE While people required to register as sex offenders (PRR) under sex offender registration and notification (SORN) policies struggle with substance use at higher rates than the general population and have limited access to substance use treatment and other social services, no research has explored or addressed how the SORN policy context influences individual and macro-level substance use risk environments. This study will qualitatively explore how SORN policies influence PRR experiences with substance use, risk of substance use related harms, and access to treatment and harm reduction services, from the perspectives of PRR and stakeholders. Results from this proposed research will inform important future multi-level interventions that address policy and social determinants of substance use and co-occurring health issues for PRR.